Testing Direct Effects of Topological and Mechanical Stress on Enhancing Anticancer and Antibacterial Drugs that Target Type II Topoisomerases

Project Summary
Topoisomerase II poisons represent some of the most widely prescribed and efﬁcacious anticancer and antibacte-
rials drugs; yet, currently, anticancer drugs can lead to cardiotoxicity and secondary malignancies, and the growing
prevalence of drug-resistant bacteria threatens the efﬁcacy of antibacterial drugs. A key step towards designing
new, more effective, and less harmful drugs is understanding the molecular mechanisms of topoisomerase II
poisons. These drugs target type II topoisomerases, essential enzymes that relax the topological and mechanical
stress that builds up on DNA during transcription, replication, and recombination. As part of these enzymes'
reaction cycle, they bind at crossings between two DNA segments, reversibly cleave one DNA segment, generating
a transient protein-DNA cleavage complex, and pass the other segment through the resulting gap. Most drug-based
poisons act as “molecular doorstops” and prevent religation of the cleaved DNA segment. As a result, enzyme
activity is inhibited and topological and mechanical stress builds up in cells; however the effects of this stress
on the poison's mechanism of action is unknown. A leading hypothesis is that the buildup of this stress further
enhances poison binding, increasing the lifetime of cleavage complexes and inhibiting enzyme activity, as well as
converting cleavage complexes to permanent DNA damage. However, recapitulating this stress in experiments
is a major obstacle in the ﬁeld. To address this obstacle, I propose to use high-precision single-molecule force
spectroscopy experiments to recapitulate physiologically relevant levels of topological and mechanical stress
and study its effects on poison binding and cleavage complex rupture with various poison-based drugs. These
experiments will provide unprecedented mechanistic insight into the effects of stress and poisons that is likely to
be important for the efﬁcacy of these drugs and help guide the development of new drugs.

Public health relevance
Project Narrative Topoisomerase II poisons represent some of the most widely prescribed an efﬁcacious anticancer and antibacterial drugs in use today, yet there is gap in our understanding of the molecular mechanism of these drugs. To address this gap, I propose to use high-precision single-molecule experiments to study the mechanism of these drugs under physiologically relevant levels of topological and mechanical stress. The results of these experiments will improve our understanding of the effects of stress on the mechanism of these drugs and is likely to lead to new insights for designing new, more effective, and less harmful drugs.